Oidos protegidos: Preventing noise exposure in farmworkers

Agriculture is an exceptionally high-risk industry. Farmworkers are commonly exposed to safety and health
hazards including extreme heat, dust, chemical exposure, and machinery operations, all of which contribute to
illness and injury. Noise exposure from loud equipment is a prevalent yet overlooked problem. In addition to
causing disabling hearing loss, excessive noise contributes to worker fatigue, stress, and an increased risk of
injury. Among the handful of noise exposure interventions in farmworkers, all have focused solely on improving
individual-level changes in hearing health behaviors and fail to recognize the social/structural context of
farmworkers’ health and safety. The NIH Health Disparities Research Framework highlights that individuals’
health behaviors are shaped by larger systems with multiple levels of influence. For farmworkers, barriers to
hearing health exist at every level, including individual (perceived seriousness), interpersonal (social norms),
organizational (workplace safety culture), and policy (lack of regulations). To address these barriers, we
propose testing a multi-level intervention tailored for primarily Latino Spanish speakers, named POP - Proyecto
Oídos Protegidos (Protected Ears Project). POP has been adapted from prior single-level interventions and will
be further refined in collaboration with a Community Advisory Board. The POP intervention addresses noise
exposure at three levels of influence: individual - farmworker knowledge and beliefs on hearing protection,
interpersonal – supervisor support of worker safety behaviors, and organizational - hearing protection on
farms. The following Specific Aims will be tested: (Aim 1) quantify hazardous noise exposures on farms using
objective dosimetry measurements and refine intervention, (Aim 2) evaluate the feasibility and efficacy of POP
on changes in noise exposures through an NIH Stage IB randomized controlled trial, and (Aim 3) evaluate
barriers and facilitators to implementing POP by interviewing farmworkers, managers, and stakeholders. Study
results will serve as the basis for a larger NIH Stage II/III comparative efficacy trial with scaled-up longitudinal
data collection to be tested in a follow-up R01. The PI, Laura Coco, PhD, AuD, is a multilingual clinical
audiologist and researcher with a background in single-level community-engaged clinical trials with Latinos to
address hearing health disparities. This K23 Mentored Career Development Award will fill gaps in her training
in occupational health, multilevel interventions, dissemination and implementation science, and independence
through professional development. In the supportive environment of San Diego State University, a Hispanic-
Serving Institution, Dr. Coco will undergo a five-year training program that includes structured mentorship,
coursework, workshops, conferences, and research. Her multidisciplinary team of mentors has unique areas of
expertise that will support her transition to research independence. Training from the K23 will provide skills that
are needed for clinical trial research addressing the broader topic of hearing health in Latino populations.

Public health relevance
PROJECT NARRATIVE Noise-induced hearing loss (NIHL) is a public health problem that is highly prevalent among farmworkers; noise is associated with worker stress, fatigue, and an increased risk for injury on the job, and hearing loss is commonly associated with communication difficulties, social isolation, and depression among other negative impacts. Intervention strategies are urgently needed to prevent noise exposure, with the NIH Health Disparities Research Framework supporting a multilevel approach that addresses different levels of influence (e.g., individual, interpersonal, organizational, and societal/policy) on hearing health. Results from this community- engaged research will inform the broader implementation and dissemination of sustainable interventions to prevent NIHL in farmworkers with potential applicability to other industries with high proportions of noise- exposed workers.